Methods Core

METHODS CORE: Project Summary/Abstract
The Methods Core (MC) is organized to position the ASSIST Center (Accelerator Strategies for States to
Improve System Transformations Affecting Children, Youth and Families) to support the identification of state
policy dissemination targets and the development and testing of accelerator strategies to optimize the
effectiveness of interventions and service delivery models for youth with serious mental health disorders
(SMHD) and their families. The MC will support all activities of the ASSIST Center, including providing
methodological support to all of the Center's investigators, including the large cadre of trainees (n=14) as well
as the early and mid-career investigators who will co-lead and provide key contributions to our three planned
research projects and four of the Core units. Working closely with the Administrative Core (AC), the MC will be
a resource to all Center investigators and the national research community via three aims: Aim 1. Identify and
develop rigorous, practical, and novel methods for state policy research for use by states, providers, health
plans/payors, and youth and families. The MC will advance the development of innovative designs, methods,
measurements and system science tools relevant to state policy research nationally. Where possible, the MC
will capitalize on state Medicaid data, administrative data, and other publicly-available datasets to advance
theory-driven, integrative, quantitative and qualitative methods for testing accelerator strategies to improve
provider performance, quality measurement, and to inform state and health plan initiatives that unfold as
healthcare shifts restructure the organization and delivery of state services. Aim 2. Provide operational support
to Center investigators. The MC will ensure that all Center research projects and pilot research projects use
rigorous design and analytic strategies through the experiences of the MC leadership, which includes expertise
in epidemiology (Co-Lead Horwitz), quantitative methods and design (Co-Lead Gibbons), qualitative and mixed
methods (Co-Lead Palinkas), and system science (Co-Investigator Luke). MC operational support will be
provided through two units: (1) the Project Design and Analysis Services Unit (co-led by McGregor, an early
career investigator, and Horwitz), which will provide design consultation, data collection and analyses, and
Institutional Review Board training and support; and (2) the Data Coordination Unit (co-led by Brown, an early
career investigator, and McKay), which will provide data management, quality assurance, and access to state
and federal administrative data warehouses; and Aim 3. Disseminate methods, data, and tools nationally. The
MC will work in coordination with the AC's Communications and Stakeholder Engagement Unit to be a national
resource for pragmatic methods and tools for large-scale state policy research, and make available data to
promote cross-state and cross-system collaborations, via dissemination strategies outlined in the AC.